2025 2026 Annual Coalition for Global Hearing Health Conferences

Project Summary
The Annual Coalition for Global Hearing Health (CGHH) Conferences serve as global hearing health hubs
to disseminate research findings, share evidence-based clinical practices, and network with a diverse group
of professionals to promote ear and hearing health and to facilitate policy changes, especially in low
resource environments. The 14th and 15th annual conferences will be held in Boston in 2025 and Agra, India
in 2026. The theme for the 2025 conference is Advancing Hearing Health in Low Resource
Communities and that of the 2026 conference is Fostering Inclusiveness, Changing Mindsets. These
themes are closely aligned with the mission of CGHH to promote and enhance hearing health services and
to improve the ear and hearing health of individuals with hearing loss in low resource communities. They
are also consistent with the recent objectives of the World Health Organization's World Hearing Forum and
its Program for Prevention of Deafness and Hearing Loss to include ear and hearing care in primary
healthcare and to reduce stigma associated with hearing loss and hearing aid use with the goal to improve
the general well-being and the quality of life of individuals with hearing loss. The keynote speakers will
address these themes from different perspectives with evidence-based research and practices. Abstract
submissions and discussions are encouraged to approach each theme from five areas: 1) Best Practices, 2)
Technology, 3) Advocacy/Community Engagement, 4) Empowering families, and 5) Training/Education. The
Annual CGHH Conferences are historically well-attended by a diverse combination of professionals and
stakeholders, who came from ~20 countries each year with many from low-to-middle income countries
(LMICs). Travel grants and registration fee waivers will be awarded to encourage local and international
students and professionals from LMICs to attend the conferences. To further expand our reach and to
increase the impact of our conferences, our Diversity Director will reach out to underrepresented groups in
the United States, to ear and hearing professional organizations in other countries, and a wide range of
professional organizations in related fields to facilitate international and cross-field learning and
collaboration, and to promote better ear and hearing services around the world.

Public health relevance
Narrative More than 1.5 billion people in the world live with hearing loss and ~80% of people with disabling hearing loss live in low-to-middle-income countries. The 2025 and 2026 Annual Coalition for Global Hearing Health (CGHH) Conference will provide a platform to share research findings, implementation strategies, advancements in technology, and best practices guidelines to improve ear and hearing health in low resource communities and to change negative mindsets regarding hearing loss. The Annual CGHH Conferences are the only conference series that is solely dedicated to improving ear and hearing healthcare in low resource environments and has a proven track record of empowering professionals to advocate for better ear and hearing healthcare around the world through the dissemination of research and providing networking opportunities.